Elucidating ecological mechanisms for propagation of antibiotic resistance genes via massively parallelized single-cell sequencing

PROJECT SUMMARY
The accelerating emergence of antibiotics resistant bacteria has become a global health crisis, costing tens of
thousands of lives and hundreds of billions of dollars every year. Horizontal transfer of antibiotics resistance
genes (ARGs) is a key mechanism driving the emergence of antibiotic resistant strains, but the ecological
processes impacting the transmission of these genes through microbial communities are largely unknown. To
address this knowledge gap, we propose to develop an ultrahigh-throughput single cell sequencing technology
to identify the associations between ARGs and microbial taxa. This method will be used to decipher the time-
dependent horizontal gene transfer networks underlying ARG spread in a human gut microbiome in response to
clinically relevant antibiotics. The new technology will enable single cell analysis of microbial communities at an
unprecedented scale. Deciphering the horizontal gene transfer networks responsible for ARG dissemination will
deepen our understanding of the ecological interactions involved in the emergence of antibiotic resistant bacteria
and inform the design of interventions to substantially reduce ARG propagation. A detailed understanding of the
environmental and ecological factors influencing horizontal gene transfer is critical to combating infectious
diseases.

Public health relevance
PROJECT NARRATIVE The emergence of antibiotic resistance bacteria that lead to infections has accelerated in recent years and is an imminent threat to global public health. The use of antibiotics is implicated in the rapid spread of antibiotic resistance, but the abiotic and biotic factors impacting these processes in microbial communities are largely unknown. To address this gap, we aim to develop a novel technology for tracking antibiotic resistance genes in complex microbial communities and apply this method to determine the mechanisms driving the spread of antibiotic resistance in a model humanized gut microbiome.